The Implications of Insurance Benefit Design for Health and Disability Among Low Income Adults with Diabetes.

Project Summary/Abstract
This career development award will establish Dr. Kimberly Narain, MD, PhD, MPH, as an independent
investigator focused on evaluating the health, aging and healthcare costs implications of social, economic and
health policies/programs, among adults with low socioeconomic status (SES), using both quasi-experimental
and microsimulation approaches. This KO8 award will provide her the support she needs to develop expertise
in 3 areas 1) analysis of administrative claims and longitudinal data; 2) aging epidemiology and SES disparities
in aging; and 3) microsimulation and cost-benefit analysis. Non-adherence to medications and treatment
recommendations due to costs is an important driver of the SES gradient in health and disability among adults
with diabetes.1 Value Based Insurance Design (VBID) strategies that reduce out-of-pocket (OOP) costs for
medications to treat diabetes and associated conditions (hyperlipidemia and hypertension) as well as disease
management appointments (primary care and endocrinologist visits) have been shown to improve medication
adherence and cardiovascular risk factor control, among privately insured individuals. However, little is known
about the effects of VBID among low income adults with Type 2 diabetes. 2,3 Understanding the effect of VBID
among low income adults is important because they face the highest disease burden associated with Type 2
diabetes and they may be particularly responsive to VBID given their higher level of price sensitivity, relative to
higher income individuals.4 However, they may also face barriers outside of costs such as low health literacy,
making the effects of VBID among this population uncertain. Additionally, it is important to know if there is any
heterogeneity in response to VBID, across baseline medication adherence levels, given that prior studies have
shown the largest effect magnitudes among subgroups with the lowest baseline medication adherence levels.
Lastly, the long-term impacts of VBID on the health, disability and healthcare costs of low income adults with
diabetes remains uninvestigated. Dr. Narain will clarify the impact of VBID among this population by examining
the impact of the Diabetes Health Plan (DHP), an employer-sponsored VBID, offered by Unitedhealthcare,
among low income (salaries < $30,000), adults with Type 2 diabetes. This project will leverage an existing data
set of more than 200 employers, housed at UCLA, to estimate both the short and long-term impacts of the
DHP, using quasi-experimental methods and a microsimulation modeling approach, respectively. The specific
aims of the proposed project are to 1) Estimate the impact of the DHP on (A) medication adherence, (B)
cardiovascular risk factors (HbA1c and LDL) and (C) healthcare utilization among low income adults with Type
2 diabetes; 2) Compare DHP treatment effects across baseline levels of medication adherence and 3)
Estimate the long-term impact of the DHP, relative to standard health insurance plans, on disability-free life
expectancy and healthcare costs among aging low income adults with Type 2 diabetes. The project will provide
key insight for informing health insurance benefit design and improving health equity.

Public health relevance
Project Narrative Non-adherence to medications and treatment recommendations due to costs is an important driver of the socioeconomic status (SES) gradient in health outcomes among adults with Type 2 diabetes.1 Value Based Insurance Design (VBID) strategies that lower out-of-pocket costs for both diabetes medications and disease management visits may improve treatment compliance and health outcomes among adults with low SES; however, little is known about the effects of VBID in this population. Understanding the short and long-term health, disability and healthcare costs impacts of VBID among low SES adults with diabetes and how these effects vary across patient subgroups will be key for informing health insurance benefit design and efforts to improve health equity.